Self-management Intervention for Reducing Epilepsy Burden among Ugandans with Epilepsy

PROJECT SUMMARY/ABSTRACT
Epilepsy is a common neurological disorder affecting over 50 million people worldwide, with majority from low-
middle income countries (LMICs). In spite of advances in treatment of epilepsy (anti-epileptic drugs and other
biological therapies), many people with epilepsy (PWE) continue to have poor quality of life (QOL), suffer from
epilepsy associated stigma and diminished mental well-being. Risk factors for poorly controlled epilepsy include;
limited social support, poor medication adherence, stigma and comorbidities like depression and substance
abuse. People with epilepsy, especially in LMIC settings, face additional challenges such as social isolation,
limited access to care and low levels of epilepsy awareness, all of which impede help-seeking and exacerbate
epilepsy symptoms and poor quality of life related to epilepsy.
Implementation of epilepsy self-management which incorporates ongoing assessment of treatment
response is the focus of this application. This application is written in response to PAR-22-097 Global Brain and
Nervous System Disorders Research Across the Lifespan, and builds upon promising pilot work in which this
study team adopted and utilized a culturally acceptable guided self-management curriculum called Self–
MAnagement for people with epilepsy and a histoRy of negative health evenTs in Uganda (SMART-U).
Preliminary work by this study team suggests that SMART-U has excellent participant acceptability, with 87.5%
retention over a 2-year period, and is associated with improved QOL and reduced stigma, depression and seizure
frequency. The lack of demonstrable efficacy under rigorous control makes it plausible for an efficacy RCT
building on pilot findings to see if SMART adds incremental clinical outcomes to PWE.
The proposed project will refine the SMART-U intervention and ensure acceptability across a broad range
of Ugandans with epilepsy and then test the effects of SMART-U intervention in improving quality of life and
reducing seizure frequency, stigma and depression and in a two site, prospective, 104–month randomized
controlled trial (RCT). We will also investigate the use of short message service (SMS) delivered via mobile
phone text to validate patient self-reported seizure occurrence and push epilepsy self-management messaging
in a practical/accessible format in SMART vs. eTAU in an LMIC. In line with Fogarty International Center (FIC)
and National Institute of Neurological Disorders and Stroke (NINDS) priorities, the proposal will build critical
research capacity for future epilepsy burden reduction. Finally, the project will grow research capacity in epilepsy
and help establish sustainable infrastructure that will facilitate future scale up of SMART in Uganda with epilepsy
partners. Taken together, the proposed project has substantial public health importance and will provide
prerequisite data and infrastructure needed to help reduce the burden of epilepsy in Uganda and other LMICs
across the globe.

Public health relevance
PROJECT NARRATIVE Epilepsy is a neurological condition with an increasing burden in many low- and middle income countries (LMICs). The chronicity of the disease, seizure complications, poorly controlled seizures, stigma, coexisting chronic diseases and social isolation negatively impact health related quality of life. This project will build upon promising pilot work and capacity building conducted in Uganda to further test a self-management program that has the potential to reduce epilepsy burden in Uganda and other LMICs.